RISE UP for Breast Cancer

ABSTRACT
RISE UP (Revolutionizing Investigations to Link Screening to Experimental Therapeutics to Upend
Prognosis for Breast Cancer) will bring an interdisciplinary, prevention-focused approach to the challenge
of eliminating breast cancer mortality. We aim to leverage what we know about targeted breast cancer
treatments to develop novel ways to approach breast cancer prevention.
The conference will bring together an international group of experts from many backgrounds and
disciplines, including (but not limited to!) physicians across women’s health specialties (oncologists,
gynecologists, radiologists, primary care providers), basic scientists, advocates, entrepreneurs, policy
makers, regulators, and investment leaders. We will apply this varied expertise to three main focus areas:
1) combining growing knowledge about new breast cancer subtypes and treatments that successfully
eliminate tumors in the early-stage setting with strategies for subtype specific prevention; 2) exploring
how best to apply trial designs using early endpoints to accelerate learning, funding, and FDA approvals
for screening and prevention; 3) integrating knowledge of breast cancer treatment and prevention with the
approaches to hormonal cycle control. Ultimately, we hope to use our knowledge about breast cancer to
reformulate the hormonal control products millions of women take to reduce breast cancer incidence.
The event will consist of talks and poster sessions to foster cross disciplinary learning, highlight research,
and spark ideas and action. General sessions will be designed to educate attendees about opportunities to
improve the health and well-being of women from prevention to treatment of breast cancer as well as
management of cycle control, contraception, menopause, and sexual health. Our goal is to bridge the
critical gap in knowledge of breast specialists and gynecologists to make breast cancer management
better, engage the gynecologic and primary care community in improvements in breast cancer screening
and prevention, and to rethink hormonal control across the continuum of a woman’s life with an eye
toward breast cancer prevention. The conference is designed to foster questions, collaborations, and
overall generation of new ideas and ways of thinking about breast cancer. There will be no overlapping
sessions so that all attendees will come out with a common set of knowledge and the ability to improve
their practice and upend the way we think about breast cancer prevention.
The conference will be held from November 1-3, 2024, at the Hotel Nikko in San Francisco. We hope
that the entrepreneurial spirit of Silicon Valley will energize attendees to challenge the status quo and act.
This notion of idea to implementation is built into the conference: we will hold a competition to
incorporate breast cancer prevention into the hormone-based care women already receive-- and a prize of
working with Bay Area biotech leaders to make that idea a reality.

Public health relevance
PROJECT NARRATIVE: RISE UP is a new breast cancer focused meeting that will bring together medical professionals from across women’s health specialties (e.g. oncologists, gynecologists, radiologists, primary care providers); basic scientists; advocates; entrepreneurs; policy makers; regulators and more, to establish new collaborations that could prove to be paradigm shifting in the breast cancer prevention space. Convening a group of interdisciplinary experts will reduce the silos that currently exist in academia, and create a dynamic, learning environment to energize the fight against breast cancer. Through three focus areas, we aim to leverage what we know about breast cancer detection, treatment and biology and hormonal management strategies to develop novel, innovative ways to approach breast cancer prevention.